The volume-regulated anion channel as a regulator of secretory activity in the intestinal epithelium

PROJECT SUMMARY
The intestinal epithelium relies on extensive cell-cell signaling to maintain a tight balance between absorptive
and secretory activity, but the intricacies of this signaling remain uncharacterized. We recently discovered that
cells infected with rotavirus, the most common cause of life-threatening diarrhea worldwide, release hundreds of
pulses of adenosine diphosphate (ADP) causing intercellular calcium waves that dysregulate uninfected cells.
Blocking the ADP receptor P2Y1 significantly reduces diarrhea severity in rotavirus-infected mice, suggesting
that this signaling is integral in regulating secretory activity. While the mechanism through which rotavirus triggers
the release of ADP has not been confirmed, our preliminary data show it relies on activation of the volume-
regulated anion channel (VRAC). VRAC is increasingly recognized as a conduit for paracrine signals
associated with a variety of intracellular stressors, but it has yet to be studied within the epithelium. Further, the
mechanisms regulating its activation in any context remain poorly understood. Therefore, the objective of this
proposal is to use rotavirus as a tool to study the role and activation of VRAC in the intestinal epithelium. Given
that rotavirus-induced intercellular calcium waves are inhibited by knock down of rotavirus non-structural protein
4 (NSP4), a Ca2+-conducting channel, my central hypothesis is that NSP4-induced elevations of cytosolic
Ca2+ activate host pathways that trigger ADP release through VRAC, amplifying secretory activity
throughout the epithelium. I will test this hypothesis by using long-term live calcium imaging in conjunction
with novel fluorescent Rho biosensors and CRISPR-Cas9 based gene editing to [Aim 1] determine the
intracellular pathway mediating VRAC activation in RV-infected cells. Given ADP release is reduced upon
pharmacological inhibition of Rho kinase or knockdown of the calcium-augmenting rotavirus protein NSP4, we
expect both calcium and Rho are involved in VRAC activation. Using both human intestinal enteroids and the
mouse model of rotavirus diarrhea, I will [Aim 2] determine the effect of VRAC activation on secretory activity in
the intestinal epithelium. This work will identify novel therapeutic targets for the treatment of secretory diarrhea,
a leading cause of mortality among children worldwide. Furthermore, our findings will address gaps in knowledge
surrounding VRAC activation and its role in paracrine signaling. Given that VRAC has been implicated in an
increasing variety of pathological processes, using this clinically relevant approach will yield information
translatable to both human health and other scientific disciplines.

Public health relevance
PROJECT NARRATIVE Secretory diarrhea remains a leading cause of mortality and morbidity among children worldwide with limited treatment options. This proposal employs rotavirus, the most common cause of fatal infectious diarrhea, to investigate the role of the volume-regulated anion channel in mediating secretory activity in the intestinal epithelium. This will unveil novel signaling pathways in the epithelium and identify potential targets for anti- diarrheal therapeutics, contributing to the NIH’s mission to develop fundamental knowledge and apply it to reduce the burden of disease.